A TRIAL OF OATS IN CHILDREN WITH CELIAC DISEASE

The hypothesis to be tested in this study is that children with newly diagnosed celiac disease (CD) may add moderate amounts of oats to their diet for 6 months with normalization of clinical, laboratory, & histologic variables. The major specific aims are to compare the effect of a gluten-free diet plus oats (GFD+O) to a gluten-free diet alone with respect to (1) small bowel injury. Secondary aims are to assess (2) immune response, (3) symptomatic response, and (4) growth & nutrition.